FEEDING STRATEGIES FOR LOW BIRTH WEIGHT INFANTS

The objectives of this study are to compare nutritional, metabolic, gastrointestinal, and neurobehavioral responses of low birth weight (LBW) infants to four orogastric tube-feeding strategies (early vs late introduction of enteral nutrition; continuous vs intermittent bolus feeding) and to describe the ontogeny of early oral feeding competence.